Targeting DDX3 for triple-negative breast cancer treatment

Combinations of metabolic deregulation and immunotherapy are gaining prominence for treating immune-
tolerant “cold” tumors, such as triple-negative breast cancer (TNBC). Evidence indicates that such treatments
can activate the immune system and induce regression of distant untargeted tumors, i.e., an abscopal effect. In
pre-clinical and clinical settings, chemotherapy and immunotherapy demonstrated superior treatment efficacy
and immune-related progression-free survival. Furthermore, chemotherapy, such as cisplatin and doxorubicin,
in combination with immunotherapy, exhibited clinically significant response rates. However, much more
research is required to optimize treatment strategies and scheduling to determine how to induce a sustained
systemic immune response with clinically meaningful outcomes.
In this application, we will leverage the use of a DDX3 inhibitor, RK-33, to alter the metabolic tumor
environment. We will combine this treatment with immunotherapy to create a tumor environment that favors an
effective response to immunotherapy. We have demonstrated that DDX3 is involved in mitochondrial
biogenesis in breast cancer cells and using RK-33 unambiguously generated mitotoxic effects with increased
reactive oxygen species production leading to breast cancer cell death, including TNBC. Also, RK-33
converted high glycolytic TNBC tumors to low glycolysis, resulting in decreased extracellular lactate, which has
been shown to facilitate an immune permissive microenvironment in TNBC. In addition, using an
immunocompetent preclinical model of TNBC, we have demonstrated that RK-33 can alter the immune profile
within a 4T1 tumor environment. As reprograming metabolic dependencies favors immune responses, we
propose a therapeutic strategy combining RK-33 treatment with immunotherapy (anti-mouse PD-1 mAb). We
propose to test this hypothesis with the following specific aims. Aim 1: Determining the effect of targeting DDX3
by RK-33 on metabolic reprogramming to improve cancer immunotherapy. Aim 2: Reprogramming the immune
microenvironment by RK-33 to enhance TNBC treatment. Aim 3: Targeting the glycolysis-immune checkpoint
axis as a potential treatment for TNBC. The goal is to disrupt the metabolic equilibrium of the tumor
environment and generate an increased efficacy of immunotherapy in TNBC.

Public health relevance
Triple-negative breast cancer (TNBC) remains an unmet medical challenge. Given the dearth of druggable targets in TNBC, there is a concerted effort to identify new strategies, such as metabolic reprogramming, to induce immune surveillance for TNBC treatment. The focus of this proposal is to test the use of RK-33, in combination with checkpoint blockade, to prevent TNBC tumor growth and determine its abscopal effect using immunocompetent preclinical models of TNBC.